STEM CELL THERAPIES FOR HUNTINGTON’S DISEASE

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. The goal of these studies is to develop new cell-based therapies for patients with Huntington's Disease. Huntington's Disease is a fatal neurodegenerative disorder for which there are currently no cures.